FOYC+ImPACT US: A digital platform for critical sexual health risk reduction curriculum customization and hybrid/remote delivery of Focus on Youth to underserved Caribbean youth in the U.S.

ABSTRACT – FOYC+ImPACT U.S.
While there is extensive epidemiological data on the high rates of HIV, STIs and unintended pregnancies among
Black populations in the U.S., this monolithic racial category problematically subsumes the ethnic diversity of
immigrant Black populations. Today one in ten Black people in the U.S. are immigrants, with the Caribbean being
the largest origin source. Caribbean immigrants in the U.S. account 46% of the total Black immigrant population
and 10% of our nation’s foreign-born population. Researchers note a variety of factors shown to impact
Caribbean immigrant’s sexual behaviors and HIV seroprevalence, including acculturation pressures (particularly
for adolescents), intersectional identities, racial discrimination, and settling in urban HIV epicenters with high
rates of STIs. While a variety of effective behavioral intervention (EBI) programs exist to address sexual and
reproductive health for Black adolescent populations, it is problematic to assume such programs, delivered as
is, will prove effective with Afro-Caribbean immigrant populations. There are no existing U.S. EBI programs
developed specifically for these populations; however, the EBI program Focus on Youth with ImPACT program
has been successfully culturally adapted and delivered in a Caribbean setting (FOYC+ImPACT). The 8-session
program, delivered in schools but including parent involvement, was evaluated through a randomized controlled
trial in the Bahamas. It was shown to be effective in improving condom use rates and skills, self-efficacy, intention
to use a condom, and HIV/AIDS knowledge. To address the gap in culturally tailored sexual health education for
youth within Caribbean communities in the U.S., we propose to develop FOYC+ImPACT U.S. This project will
(1) revise the FOYC+ImPACT program in a new, broader context, making it customizable and scalable across
Caribbean communities in the U.S.; 2) develop a cloud-based platform in which educators can build their own
customized curriculum for FOYC+ImPACT U.S. in which all program components are modularized and made
available in both e-learning and in-person formats; 3) address cultural tailoring needs by allowing teachers to
customize their course content by age, imagery shown, components (non-core) to include, and country/region-
specific content and linguistic references; and 4) increase implementation fidelity through providing online
materials, fidelity tracking, and implementation prompts. The primary goal of this Phase 1 project is to test the
feasibility of developing a digital platform that allows for implementation with fidelity of FOYC+ImPact U.S. in
diverse Caribbean community settings in the U.S. The Phase I project will include development of the cloud-
based platform with two lessons made available with customization of delivery formats and content/text/imagery
to meet needs of various Caribbean communities. A pilot test will be conducted to assess the impact on student
knowledge and improvement in implementation fidelity. Phase II will complete the remaining lessons, add new
lessons/content to update the program, and demonstrate effectiveness through a randomized controlled trial.

Public health relevance
PUBLIC HEALTH NARRATIVE Afro Caribbean immigrants make up 10% of our nation’s foreign-born population, yet their cultural diversity is not reflected in epidemiological data on the high rates of HIV, STIs, and unintended pregnancies among U.S. Black populations. Complex factors impact Caribbean immigrant’s sexual behaviors and HIV seroprevalence, including acculturation pressures – particularly for adolescents – intersectional identities, discrimination, and living in urban HIV epicenters. Yet there are no existing effective behavioral intervention (EBI) sexual health programs specifically created for this population. To address this need, this project will build on prior research culturally adapting and delivering the EBI program Focus on Youth+ImPact in the Bahamas, where it was shown to be effective in improving condom use rates and skills, self-efficacy, and HIV/AIDS knowledge. will create and test a prototype cloud-based, customizable intervention, Focus on Youth Caribbean+ImPACT U.S., in a digital platform for educators and parents in diverse U.S. Caribbean communities. This project